Mechanisms and In Vivo Efficacy of Synergistic Acid Ceramidase and Bcl-2 Inhibition in Acute Myeloid Leukemia

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) is an aggressive, heterogeneous myeloid malignancy that results in bone marrow
failure. The Bcl-2 antagonist/BH3-mimetic, venetoclax (VEN), is used in combination with chemotherapy or
hypomethylating agents to treat newly diagnosed AML patients unable to tolerate induction chemotherapy.
However, relapse rates remain high due to de novo and acquired resistance attributed to mitochondrial
reprogramming and upregulation of compensatory survival proteins like Mcl-1 and Bcl-xL. Strategies that
antagonize mitochondrial respiration, induce the integrated stress response (ISR), and/or reduce Mcl-1/Bcl-xL
protein expression are known to improve VEN sensitivity. Importantly, sphingolipid (SL) metabolism,
mitochondrial respiration, the ISR, and Mcl-1 protein levels are closely linked, making SL metabolism an
attractive therapeutic target in combination with VEN. The balance of pro-apoptotic ceramides and pro-survival
sphingosine-1-phosphate form the bioactive core of sphingolipid signaling. Acid ceramidase (AC) is a lipid
hydrolase that catabolizes pro-apoptotic ceramides. We previously demonstrated that AML blasts rely on AC for
survival. Because we and others showed that AC inhibition severely impairs mitochondrial respiration, we sought
to determine whether combining AC inhibitors with VEN could be effective for treating AML. Our preliminary data
show that AC inhibition improves VEN sensitivity in human AML cell lines and patient samples. However, the
mechanisms underlying the synergy from this novel combination are unknown, and the in vivo efficacy of
combinatorial AC and Bcl-2 inhibition has not been explored. We hypothesize that synergy between AC and Bcl-
2 inhibition results from SL-mediated impairment of mitochondrial form, respiration, and ISR overactivation.
Aim 1 (F99 phase) is designed to complete my dissertation work by characterizing the mechanism, biomarkers,
and in vivo efficacy of combined AC and Bcl-2 inhibition in AML. To accomplish these goals, we will analyze
mitochondrial form and function, interrogate the role of the ISR for synergy, and utilize computational approaches
to define biomarkers of drug responses. My overarching career goal is to develop into a highly productive,
independent cancer researcher focused on developing novel SL-based therapeutics and precision medicine. To
best prepare myself to start an independent cancer research program, I will utilize the K00 period to i) learn new
skills in dynamic BH3 profiling (a precision medicine assay), CRISPR-Cas9 screening, and genomic data
analysis; and ii) expand my cancer research portfolio into solid tumors by studying triple-negative breast cancer.
Thus, Aim 2 (K00 phase) will evaluate the relationship between SLs and mitochondrial apoptotic priming using
dynamic BH3 profiling and will utilize CRISPR screening to identify novel SL-based combination therapies to
treat triple-negative breast cancer. The training plans in the F99/K00 phases will help me successfully achieve
my career goals and thrive as an independent cancer researcher.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) remains an incurable malignancy despite the recent approval of molecularly targeted therapies. The Bcl-2 antagonist/BH3 mimetic, venetoclax, is routinely used in combination with chemotherapy or hypomethylating agents in newly diagnosed AML, but incomplete responses demonstrate a need for novel treatment modalities to improve venetoclax efficacy. The F99 phase of this proposal investigates the mechanisms of synergy and in vivo efficacy of co-inhibiting the pro-survival sphingolipid enzyme, acid ceramidase, and Bcl-2 in AML, while the K00 phase leverages CRISPR screening and dynamic BH3 profiling to develop rational sphingolipid-based drug combinations in breast cancer.